Research Education Component

PROJECT SUMMARY RESEARCH EDUCATION COMPONENT
As the population continues to age there will be an even higher percentage of individuals over 70 years of age
with a subsequent increasing percentage of individuals affected by aging-related diseases, such as
Alzheimer’s disease (AD) and related disorders (ADRD). The Stanford Alzheimer’s Disease Center (ADRC)
Research Education Component (REC) aims to provide training to the next generation of clinicians and
scientists in dementia-related research, ensuring a strong and diverse workforce prepared to respond to this
public-health crisis. The REC supports the vision of the Stanford ADRC to serve as a shared resource to
facilitate and enhance multidisciplinary and interdisciplinary research in AD/ADRD. The REC will provide a
comprehensive, formalized mentored training program to support 2 trainees per year to pursue research in and
to become leaders in the fields of aging, and AD/ADRDs. Along with the Leadership Team, the REC includes
an exceptional group of mentors from the Stanford ADRC and across the broader Stanford community, who
will serve as faculty to the REC Scholars. Formal didactics and coursework will complement clinical research
training opportunities and a mentored research project leading to a manuscript and with the goal of submission
of a Career Development Award or Independent Research Award.